BASIS AND MODULATION OF THE INNATE IMMUNE DEFECT IN FIV

DESCRIPTION: (provided by applicant) Deficiencies in the innate immune response of HIV infected people and FIV infected cats are well documented. The defect often presents clinically as reduced competence in eliminating intracellular opportunistic pathogens. Not only is innate immunity responsible for the control and elimination of the majority of opportunistic infections, it is the innate response that initiates the type and strength of the adaptive immune response. The nature of the innate immune defect in HIV infection has been most convincingly associated with decreased macrophage function, natural killer (NK) cell function, cytokine dysregulation (decreased IFN-y, ILl 5, TNF-a, or elevated ILl 0) and immunosuppression by specific viral proteins (gp4l, gpl 20, and Tat). However, the majority of the data has been generated in vitro, thus the significance in vivo is largely unknown. The studies proposed here are designed: 1.) To define the cellular and cytokine defects associated with impaired innate immunity of Fl V-infected cats to a well-characterized intracellular opportunistic pathogen, L. monocytogenes; 2.) To modulate the innate response of FlV V-infected cats by introducing IFN-7, IL10 0, ILl 5, or TNF-.a into the milieu; 3.) To determine if lentivirus Tat or envelope glycoproteins are immunosuppressive in the absence of infection and; 4.) To determine whether suppression or modulation of the innate immune response impacts the adaptive immune response. As preliminary work, the investigators have developed the model of L. monocytogenes as an immune system probe in Fl V-infected cats and have performed initial characterization of the cellular and cytokine response. Completion of the specific aims proposed here will better define the innate immune defect, identify potential points for intervention/modulation, and validate an animal model for the future evaluation of immune-modulating compounds.ompounds.